RFA-IP-23-007, Collaborative Surveys to Provide Inputs into Vaccine-Related Economic Evaluations

PROJECT ABSTRACT
Immunizations are one of the most effective types of health interventions available. This research study will
provide relevant information for a variety of stakeholders, including ACIP members, CDC decision makers,
patients, parents, providers, and payers, through the development and implementation of economic survey
studies that will answer a series of research questions that directly address the Healthy People 2030
Objectives relating to vaccination and vaccination coverage. Working jointly with CDC co-investigators, the
PAVVE research team will identify and prioritize vaccination survey topics, design and implement surveys, in
order to provide timely data for high-priority immunization policy decisions. Working collaboratively with CDC
scientists and PAVVE investigators, we will employ innovative economic survey methods across 6 studies to
inform vaccine policy decisions. The overall goal of this research study is to obtain information to inform
vaccine policy and the development of effective interventions to optimize vaccination uptake.

Public health relevance
PROJECT NARRATIVE This research study will use economic survey methods to collect data on public/parent/patient preferences for vaccine outcomes and vaccination programs. Using this information, the CDC will be better able to measure the value of future vaccination programs and to design strategies to increase uptake of vaccination.